Dinitroaniline Specificity for Tubulin

[unreadable] DESCRIPTION (provided by applicant): Dinitroanilines compounds inhibit tubulin polymerization in diverse plants and in protozoa but do not disrupt vertebrate or fungal microtubules. These compounds disrupt microtubules in protozoan parasites including Trypanosoma spp., Leishmania spp., Entamoeba spp., Plasmodium falciparum, Cryptosporidium parvum and Toxoplasma gondii. Unfortunately, the poor water solubility of dinitroanilines prevents their development as anti-parasitic agents. Unlike all previously characterized microtubule-disrupting drugs, which bind beta-tubulin, the dinitroanilines act on alpha-tubulin. The experiments in this proposal seek to define the effect of dinitroanilines on alpha-tubulin and to identify soluble derivatives of the dinitroanilines. The yeast S. cerevisiae is normally insensitive to dinitroanilines but expression of altered tubulin is predicted to confer dinitroaniline sensitivity. Sensitive and resistant yeast strains will be used to develop an inexpensive high throughput screen for effective and soluble dinitroaniline derivatives. The screen will exploit growth competition between sensitive and insensitive S. cerevisiae strains to discriminate between compounds that are non-specifically toxic to both strains and those that specifically disrupt plant/protozoan-like tubulin. Dinitroaniline derivatives will be evaluated in the yeast growth competition assay to identify compounds with increased solubility, sub-micromolar activity and specific disruption of plant/protozoan-like microtubules. Active compounds identified by the yeast screen will be tested for specific disruption of parasite microtubules using intracellular Toxoplasma gondii. Dinitroaniline interaction with alpha-tubulin will be characterized by mapping the dinitroaniline binding site on tubulin, characterizing the kinetics of dinitroaniline binding to the tubulin dimer, identifying conformation changes associated with dinitroaniline binding and describing dinitroaniline effects upon the dynamic behavior of microtubules. [unreadable] [unreadable]